Predicting Ipsilesional Motor Deficits in Stroke with Dynamic Dominance Model

Project Summary:
In the previous cycle of this grant, we characterized hemisphere-specific motor control deficits in the non-
paretic arm of unilaterally lesioned stroke survivors. Our preliminary data indicate these deficits are
substantial and functionally limiting in patients with severe paresis. We have specifically designed an
intervention to remediate the hemisphere-specific deficits in the non-paretic arm, using a virtual-reality
platform, and then follow this training with manipulation training of a variety of real objects, designed to
facilitate generalization and transfer to functional behaviors encountered in the natural environment. We
propose a 2-site, two-group randomized intervention with a treatment group, which will receive unilateral
training of the non-paretic arm, through our Virtual Reality and Manipulation Training (VRMT) protocol. This
intervention protocol is grounded in the premise that targeted remediation of fundamental control deficits
exhibited by the non-paretic arm will generalize and transfer beyond practiced tasks to performance of
activities of daily living (ADL). This approach contrasts with the more pragmatic approach of task-specific
training of essential ADL’s, which is limited in scope, more cumbersome, and ignores known fundamental
motor control deficits. Our control group will receive conventional intervention, guided by recently released
practice guidelines for upper limb intervention in adult stroke. The impact of the proposed research is that we
address persistent functional performance deficits in chronic stroke patients with severe paresis, who’s non-
paretic arm impairments are generally ignored in most current rehabilitation protocols. Our first aim addresses
the overall effectiveness of this intervention, relative to our control group: To determine whether non-paretic
arm VRMT in chronic stroke survivors with severe paresis will produce durable improvements in non-paretic
arm motor performance that will generalize to improve functional activities and functional independence to a
greater extent than conventional therapy focused on the paretic arm. Our second aim focuses on the
mechanistic basis of potential training-related improvements in motor performance: To determine whether
intervention-induced improvements in non-paretic arm performance are associated with improvements in
hemisphere-specific reaching kinematics. Finally, our third aim monitors for potential negative effects of our
experimental intervention on paretic arm impairment. We have already integrated the PI’s laboratories
(Sainburg-PSU, Winstein-USC) for our pilot research project that has provided excellent support for aims 1
and 3.
!

Public health relevance
Project Narrative: Stroke survivors with severe chronic paresis who are not able to use their paretic hand for manipulations, often have substantial motor control deficits in the non-paretic arm that can substantially limit functional independence. This proposal will test remediation focused on improving functional independence by training control and coordination of the non-paretic arm. It will also test the effects of this intervention on paretic arm motor impairment. If successful, this study will provide rigorous evidence for a therapy that remediates persistent functional performance deficits in chronic stroke patients with severe paresis, who's non-paretic arm impairments are generally ignored in most current rehabilitation protocols. ! ! !